Institutional Training in the Genomic Sciences

Abstract
The Genomic Sciences Training Program (GSTP) at the University of Wisconsin-Madison is
building an inclusive community of leading genomic scientists with strengths spanning across
multiple disciplines. The training opportunities and environment we propose will enable our
trainees to create and rigorously apply new tools derived from technological advances that are
informed by cutting-edge statistical and computational approaches that functionalize diverse
and large datasets. The new genomic approaches to biological and medical investigation
demand scientists who are knowledgeable and skilled across several fields in effective ways that
potentiate new insights or inventions. Accordingly, the emergence of new tools allowing for the
creation and interpretation of large-scale experimental efforts is what GSTP has focused on by
the didactical interweaving of investigative approaches drawn from multiple fields (biology,
genetics, physical sciences, engineering, computer science, and statistics) that were
individually contoured for complementing a trainee’s core disciplinary focus, yet built upon
achievement and knowledge within the genomic sciences. Given the incredibly rich scientific and
engineering breadth of the University of Wisconsin, GSTP has been able to recruit outstanding
trainees who greatly advanced mass spectrometry, “omic”-integration, computation, genome
engineering, and bio-devices, while exploring new applications leveraging these advantages for
cutting-edge investigation into network genomics, proteomics, spatial genomics, metabolomics,
and genome biology. These achievements and contributions have nucleated and grown a
significant genomics community. This genomics community has become a gateway and
central hub for groundbreaking collaborations reaching across departments, centers, schools
and other training programs. We propose for the upcoming project period that we continue this
focus, with continued emphasis on innovation/invention and fostering of clinical applications,
which will advance translational genomics and “turn discoveries into health.” We request funding
for 10 predoctoral and 4 postdoctoral traineeships per year. In the next funding period, we will
continue to recruit and train trainees who have recently completed their undergraduate or
graduate degrees.

Public health relevance
Project Narrative Modern medical practice is now relying on the fruits of genomic research for analyzing the genetic makeup of patients and their cancers. New medical treatments are increasingly being tailored to individual patients for increasing their effectiveness and lessening side-effects. We propose to train scientists who will be developing the systems and analysis that will enable greater use of genomic information for biomedical researchers and the general public when they see a doctor.